Progression of Early Atrophic Lesions in Age-related Macular degeneration

SUMMARY
We will focus on a previously largely under-explored but highly relevant time window in progression of
age-related macular degeneration (AMD), i.e., `early atrophic AMD'. We postulate that a therapeutic effect
in early atrophic AMD would probably save a large proportion of patients from progressive visual function loss
and that it seems more justifiable to risk interventions in this time window than in earlier AMD stages. Against
this background, a comprehensive knowledge of the natural disease progression in this potential
therapeutic margin is essential. We will implement innovative multimodal high-resolution retinal imaging,
comprehensive functional testing, and assessment of vision-related quality of life (VRQoL) combined with
standardized and exploratory analysis strategies in a prospective, longitudinal study. This will enable us to
characterize and quantify the microstructural changes and associated functional and VRQoL deficits in
eyes with early atrophic lesions with unprecedented accuracy. Knowledge of the strongest risk factors for
accelerated disease progression will allow identification of patients at highest risk for visual function loss.
Moreover, our hypothesis on disease-stage specific risk-factors may guide selection of therapeutic targets that
are particularly susceptible in early atrophic AMD. Tailoring therapeutics to specific phenotypes and disease
stages may be key to prevent irreversible vision loss and the associated reduced quality of life in patients with
AMD.

Public health relevance
PROJECT NARRATIVE Early atrophic age-related macular degeneration (AMD) represents an important time window in the course of so far untreatable atrophic AMD, as patients typically experience only some degree of visual dysfunction, while being at significant risk for marked further loss of vision. To allow the precise evaluation of upcoming therapeutic interventions, a better understanding of the manifestation and variable disease progression is needed. This project aims to investigate refined tools to detect and monitor early atrophic AMD more accurately, including the impact on visual dysfunction and quality of life.